Administrative Core

ADMINISTRATIVE CORE

The SASCO Administrative Core will bring together the activities of the Center under the leadership of the MPIs with the support of experienced staff for research center administration and data management. We supplement the Administrative Core with i) an Organizational Lead to enhance research perspectives and scientific rigor within the Center, ii) a Leadership Team for centralized decision-making, and iii) a Resource Management Team in charge of data sharing and model accessibility. The intra-center pilot project program will be managed by the Leadership Team as a vehicle for welcoming junior faculty and postdoctoral fellows. The Administrative Core is conscientious about long-term stewardship of the Center and has clear criteria for the External Advisory Board that it will recruit. Collectively, the Administrative Core will facilitate communication and logistics among Center components and with the broader Cancer Systems Biology Consortium.